Cancer Epigenetics Research Program

PROJECT SUMMARY: CANCER EPIGENETICS RESEARCH PROGRAM
The Sylvester Comprehensive Cancer Center (Sylvester) Cancer Epigenetics (CE) Research Program is
composed of 26 members from nine departments and co-led by Ramin Shiekhattar, PhD, and David Lombard,
MD, PhD, who bring complementary expertise and knowledge to the program. CE aims to pinpoint epigenetic
factors and mechanisms that contribute to cancer risk, initiation, progression, and treatment resistance. It
endeavors to develop innovative approaches to epigenetics research to mitigate the impact of cancer in
Sylvester’s catchment area (CA), a highly diverse four-county area known as South Florida (SoFL). The CE
program’s three specific aims are to 1) elucidate the oncogenic molecular mechanisms associated with
epigenetic regulators that are mutated or dysregulated in cancer; 2) define the enhancer and transcriptional
reprogramming imposed by aberrant signal transduction and altered metabolism in cancer; and 3) identify and
validate epigenetic mechanisms and targets as the basis for biomarker development and therapeutic
intervention. CE members receive $4.6M in annual direct peer-reviewed funding, with $1.6M from the NCI and
$1.5M in 11 multi-principal investigator (MPI) grants. During the current reporting period (6/1/2018-5/31/2023),
CE members published 252 cancer-related papers; 20% represent intra-programmatic, 32% represent inter-
programmatic, and 82% reflect multi-institutional collaborations. Forty-four percent of CE’s publications are in
top-tier journals with an impact factor greater than ten. CE works collaboratively with Tumor Biology to
understand the interplay between oncogenic signaling and epigenetic dysregulation in cancer, with Cancer
Control to understand how environmental and socio-economic disparities impact the epigenome and influence
cancer initiation and progression, and with Translational and Clinical Oncology to translate findings made by
CE researchers into clinical trials. These efforts are supported by NCI and NIH R01 grants, Department of
Defense awards, and a newly awarded Leukemia and Lymphoma Society Specialized Center of Research
program project grant. CE’s research efforts leverage Sylvester’s Shared Resources (SRs), particularly the
Onco-Genomics, Flow Cytometry, Cancer Modeling, Biospecimen, and Biostatistics and Bioinformatics SRs.
Major CE discoveries during the reporting period include the 1) paradigm-shifting demonstration that the
Polycomb Repressive Complex 1 promotes estrogen receptor-dependent oncogenic gene expression in breast
cancer; 2) elucidation of epigenetic mechanisms underlying the changes in enhancer function in hematopoietic
stem cells in the aging process, relevant to Sylvester’s aging and cancer cross-cutting theme and its large and
diverse elderly population in its CA; and 3) demonstration that targeting LSD1 can potentiate the clinical activity
of differentiation therapy in patients with myelodysplastic syndrome or acute myeloid leukemia. CE strives to
elucidate basic epigenetic abnormalities underlying cancer initiation, progression, and therapeutic resistance,
and mechanisms that can be targeted to enhance the effectiveness of cancer treatments.